Connect through PLAY: A staff-based physical activity intervention for middle school youth

Abstract. Although afterschool programs (ASPs) have been recognized as a critical context for promoting
youth physical activity (PA), with broad reach to underserved communities, research by the PI and others have
indicated that ASPs continue to struggle to meet policy guidelines for daily youth PA. Moreover, despite
continued increases in obesity rates among U.S. adolescents, there have been few ASP interventions focused
on underserved adolescents, and limited-to-no impact on adolescents' sustained behavior change. Previous
ASP studies by the PI demonstrate that social mechanisms overlooked in previous interventions (e.g.,
developing friendship and connection to peers and staff through PA; group belonging, including positive peer
PA norms and tangible support) are key predictors of youth PA. The research team recently completed a
feasibility trial (NIH R21 HD077357) within 6 ASPs (3 intervention vs. 3 standard- health curriculum controls)
for underserved middle school youth that was the first intervention to date to address these youth PA social
goals/mechanisms. Findings showed positive effects for changing staff behaviors, improving youth PA social
supports and connections with peers and staff, and increasing youth PA. The proposed study will expand on
the previous ASP feasibility trial with a novel translational approach that works with pre-existing ASPs and
targets staff as instrumental for sustainable changes in social mechanisms within the ASP setting for
increasing the daily PA of underserved adolescents. The proposed project will be a prospective, randomized
controlled trial comparing a staff-based social development PA program to a standard ASP health curriculum
control. The proposed efficacy trial will enhance the influence of pre-existing ASP staff as key change agents
and address social developmental needs of adolescents overlooked in previous interventions through
employing a novel theoretical framework that expands on social developmental theory and the social
mechanisms highlighted by Self-Determination Theory, Achievement Goal Theory, and Social Cognitive
Theory. The intervention will target the three key social mechanisms of “PA social affiliation goals” for
increased and sustained PA of staff and underserved middle school youth (i.e., Friendships/connections
through PA; Group Belonging, and; Staff Connection). All components of the intervention (health promotion
initiative, comprehensive training, and tailored social PA curriculum) aim to improve staff capacity for facilitating
a PA context that supports these social goals/mechanisms (connections, group belonging) and increases the
influence of ASP staff as positive PA role models and agents of change. Compared to control ASPs, ASPs
receiving the `Connect' program are expected to show greater improvements from baseline to post- and 6 mo
follow-up in social mechanisms, youth PA, and staff PA. The results of this proposed project will demonstrate
the efficacy of the intervention, and will assist in developing a model of training, motivating, and empowering
ASP staff to address social mechanisms that promote youth PA for conducting a large scale effectiveness trial.

Public health relevance
Project Narrative This study provides a novel translational approach that works with pre-existing afterschool programs and targets staff as instrumental for facilitating changes in critical social mechanisms within the setting for sustained increases in the daily physical activity of underserved adolescents. This research is important for increasing the potential impact of school- and afterschool- based health interventions. Increasing and sustaining adolescents' physical activity has significant public health and economic implications for weight control, reducing chronic disease, and increasing longevity and quality of life, especially among an underserved population of youth who are at greatest risk for obesity and related diseases.